Johns Hopkins University NCTN Lead Academic Site Program

Project Summary/Abstract
Johns Hopkins has been an academic member institution of cooperative groups since the founding of this
national oncology research initiative. Over the decades, our faculty have provided strong clinical and
laboratory scientific leadership, and administrative leadership to the cooperative groups. Our primary goal is to
provide scientific leadership thus bringing innovative translational science developed in pre-clinical and early
phase trials at Johns Hopkins via mechanisms such as the ETCTN to the National Clinical Trials Network
(NCTN) for further development. Our faculty serve in leadership roles as study PIs and laboratory PIs, disease
and modality committee chairs. The majority of our contributions and our longest association remains with
ECOG-ACRIN and secondly with NRG. In the upcoming extension, we plan to continue activities in support of
our aims: 1) To provide scientific leadership within the NCTN groups and their disease-oriented committees.
2) To bring correlative translational research, novel imaging and radiation techniques, cell biology and
molecular biology, into clinical trials for all stages of cancer. 3) To strengthen and enhance the coordinated,
collaborative, and inclusive infrastructure established under one administrative program in order to support
NCTN projects and promote participation in order NCI-supported projects, such as the ETCTN. 4) To address
the challenges of supporting participation and accrual across disciplines, modalities, rare and diverse patient
populations at all Johns Hopkins Kimmel Cancer Center locations. 5) To promote the involvement of junior
faculty in all our aims for their advancement and contribution to the NCI cancer program. These goals will be
accomplished through the mission of the Johns Hopkins Kimmel Cancer Center. Johns Hopkins investigators
also focus on enhancing minority participation in clinical trials through grants as well as increasing overall
clinical trial accrual throughout Johns Hopkins Kimmel Cancer Center sites. We anticipate uninterrupted
continuity of our level of contribution to the NCTN in the upcoming year of extension.

Public health relevance
Project Narrative Johns Hopkins has an extraordinary institutional commitment to the health of the public. Through close collaboration across multiple disciplines, the Cancer Center is focused on the entire spectrum of cancer care from risk identification, screening and prevention to early detection and cancer treatment. This patient centered care addresses the effects of cancer on financial stability, family and social interactions and quality of life, encompassing the overall impact of cancer on the lives of patients.